KATRITCH- UNIVERSITY OF SOUTHERN CALIFORNIA DMFP FOR BPN-35269 - CURIA GLOBAL, INC.

CRO will develop and qualify the analytical methods
required to support the manufacture of API (demo, toxicology and GMP batch).

Public health relevance
Developing therapies for neurological disorders